SWOG BIQSFP Projects GY10

This is a supplement application for Biomarker, Imaging and Quality of Life Studies Funding
Program (BIQSFP) funding for the following SWOG Cancer Research Network studies:
S1608, S1803, S1827, S2114 and S2212.
Additionally, this request contains the progress reports for the following additional studies:
S1500, S1612, S1929, S1418 and S1826.
The report for S1314 is a final progress report.

Public health relevance
This is a supplement application for Biomarker, Imaging and Quality of Life Studies Funding Program (BIQSFP) funding for the following SWOG Cancer Research Network studies: S1608, S1803, S1827, S2114 and S2212. Additionally, this request contains the progress reports for the following additional studies: S1500, S1612, S1929, S1418 and S1826. The report for S1314 is a final progress report.